The Role of MKK3b in the Mechanical Activation of mTORC1, Protein Synthesis, and Skeletal Muscle Growth

Project Summary/Abstract
Mechanical stimuli play a major role in the regulation of skeletal muscle mass and the maintenance of muscle
mass significantly contributes to disease prevention and quality of life. While the link between mechanical stimuli
and the regulation of muscle mass has been appreciated for decades the exact mechanisms that control this
process remain poorly defined. Current models assert that mechanically induced increases in muscle mass are
driven by a positive shift in the balance between protein synthesis and degradation which, in turn, leads to the
net accumulation of newly synthesized proteins and muscle growth. Work from our lab and others has identified
the mechanistic target of rapamycin complex 1 (mTORC1) as a major regulator of this process, however, little is
known about the upstream pathway(s) that control the activation of mTORC1 and/or related events that
potentially contribute to the mechanical regulation of protein synthesis and growth. In an effort to identify these
pathway(s) our lab recently performed a phosphoproteome-wide analysis of the signaling events that occur in
response to endurance and resistance exercise in humans. The rationale behind this study was based on the
recognition that resistance and endurance exercise lead to very distinct muscular adaptations with endurance
exercise promoting an increase in aerobic capacity whereas resistance exercise induces an increase in protein
synthesis and growth. Thus, we reasoned that our analyses would lead to the identification of signaling events
that are activated specifically by endurance and resistance exercise. We were particularly interested in the
resistance exercise-specific signaling events because these would represent potential members of the upstream
pathway(s) that promote the activation of mTORC1, protein synthesis, and growth. The outcomes of these
analyses revealed that mitogen-activated protein kinase kinase 3b (MKK3b) undergoes a prolonged activation
following resistance but not endurance exercise and that this event is highly correlated with the increase in
myofibrillar protein synthesis following resistance exercise (R = 0.87). Follow-up studies also revealed that the
prolonged activation of MKK3b is conserved in a mouse model of resistance exercise and that the activation of
MKK3b is sufficient to induce mTORC1 signaling, protein synthesis, and muscle growth. Thus, my overarching
hypothesis is that MKK3b is a central component of the upstream pathway via which mechanical stimuli induce
the activation of these processes. In the proposed project I will determine whether MKK3b is necessary for the
activation of mTORC1, protein synthesis, and muscle growth by employing skeletal muscle-specific and
tamoxifen-inducible MKK3b knockout mice, two complementary but distinct models of mechanically induced
growth, advanced imaging techniques, and our innovative method for visualizing and quantifying the
accumulation of newly synthesized proteins. Collectively, these studies will not only address a major gap in
knowledge regarding the mechanism(s) whereby mechanical stimuli regulate muscle mass, but they will also
propel me toward my goal of becoming a principal investigator at a research-intensive institution.

Public health relevance
Project Narrative This project is relevant to public health because the outcomes will facilitate studies that are aimed at developing therapies that can attenuate or reverse the loss of skeletal muscle that occurs during a variety of conditions such as prolonged bed rest, cachexia, muscular dystrophies, myopathies, immobilization, and aging.